Activation of type I interferon production in human immune cells by cell-to-cell transmission of HIV-1

ABSTRACT
Type I interferon (IFN) is an important cytokine that not only functions as host innate immune response
against infection but also regulates inflammation and immunopathogenesis process. IFN production
mediated by cGAS/STING signaling pathway, which senses cytosol DNA, is one of fundamental systems
found in a variety of viral infections. However, mechanisms of how HIV-1 infection induces production of IFN
in immune cells has been incompletely understood for decades. Clinical studies have demonstrated
elevated IFN activity in people living with HIV-1. In similar, persistent IFN expressions were found in
HIV/AIDS animal models. However, in vitro studies using cell-free HIV-1 viruses reported poor induction of
IFN production triggered by cGAS/STING signaling pathway. Interestingly, in a pilot study, we found that
HIV-1 cell associated infection, a mode of viral transmission through direct cell to cell contact that yields
rapid virion transfer and much efficient replication, activated IFN expression by triggering cGAS-STING
signaling pathway in cultured MT2 cells. Therefore, in this study, we hypothesize that cell-to-cell
transmission of HIV-1 activates productions of IFNs and inflammatory cytokines by inducing
cGAS/STING pathways. We have developed two cell based models to study cell-to-cell transmission of
HIV-1 independent of cell free virus infection in both cultured and primary human immune cells.We propose
to test our hypothesis by two specific aims. Aim 1. To investigate whether HIV-1 cell-to-cell transmission
activates IFN production by inducing cGAS/STING/IRF-3 pathway. We will investigate and confirm the
activation of this pathway specifically by cell associated infection. We will further verify that cGAS is the
sensor of this pathway activation and identify factors that triggers this activation under unique virological
and cellular environments during cell associated trasmission of HIV-1. Aim 2. To investigate whether HIV-
1 cell-to-cell transmission triggers cGAS/STING/NF-κB pathway. We will examine changes in status of
this signaling pathway activation after cell-to-cell transmission of HIV-1. We will also investigate if cell
associated infection reactivates HIV-1 in latency through upregulating NF-κB. Understanding the role of HIV-
1 cell-to-cell transmission in the activation of IFN with well characterized signaling pathways will represent
a new way to fulfill our understanding in the pathogenesis of HIV infection as well as providing a potential
guide to therapeutic approaches. This study will also provide great opportunity of research collaborations
and extensive learning experience for students at ACPHS.

Public health relevance
Narrative This study is proposed to investigate whether cell-to-cell transmssion of HIV-1, an efficient form of virus dissemination through direct contact between infected and uninfected cells, activates type I interferon (IFN) production with defined molecular pathways.